Women's Reproductive Health Research at the University of Washington

PROJECT SUMMARY/ABSTRACT
The Women’s Reproductive Health Research (WRHR) program, an early career development program for
obstetrician gynecologists, was established at the University of Washington (UW) in 1998. The aim of the UW
WRHR program is to foster the education, training and scientific development of obstetrician gynecologists who
demonstrate clear research potential and who are committed to a career in academic medicine. Our long-term
goal is to improve women’s health and all those who seek Ob/Gyn care. The program has successfully trained
14 individuals, with 2 scholars currently in training.
This proposal describes a plan for continuation of the UW WRHR program. Our goal is to provide research
training and mentorship tailored to specific interests enabling early career physicians to establish their research
programs and become independent scientific investigators. Our WRHR career development training program
consists of an intensive multidisciplinary mentored experience for 2-5 years with 2 positions available per year.
During this period, a scholar devotes at least 75% of their time to research. We aim to recruit individuals to our
WRHR Program from other institutions and from under-represented backgrounds.
The UW WRHR encourages cross-disciplinary research and is designed to provide training environments that
create optimal growth opportunities for academic researchers. We have a distinguished group of 24 mentors
with a wide spectrum of research expertise from genomics to global health and beyond. Our scholars incorporate
these skills into research centered in obstetrics, gynecology, and women’s reproductive health. Program
strengths include reproductive immunology, infectious disease, genetics, molecular biology, bioengineering,
disease prevention, health care disparities, prematurity and global health. Through partnerships with outstanding
scientists in disciplines that lie outside of the traditional boundaries of obstetrics and gynecology, our scholars
have the greatest opportunity to achieve their scientific potential, build unique and successful interdisciplinary
careers, and advance the health and well-being of women and their families. The Department of Obstetrics and
Gynecology and the School of Medicine at UW are prepared to make major commitments to support continuation
of the UW WRHR program to positively impact the health of women and all those that seek Ob/Gyn care around
the globe.

Public health relevance
PROJECT NARRATIVE The UW Women’s Reproductive Health Research (WRHR) Program provides a wholistic approach to the career development of Ob/Gyn faculty as physician scientists by providing a strong multidisciplinary mentorship team to facilitate team science, cutting-edge research training, effective communication skills, and effective coaching to enable a successful transition to independent funding.